Antiretroviral therapy adherence and exploratory proteomics in virally suppressed people with HIV and stroke

PROJECT SUMMARY
Antiretroviral therapy (ART) has dramatically changed the health outcomes of people with HIV (PWH). Newer
ART regimens with more robust viral suppression may allow complacency creep for imperfect adherence, given
the regimen forgiveness for achieving suppressed viral loads despite imperfect adherence. In turn, imperfect
adherence may lead to ongoing viral replication below the clinically-relevant suppression threshold, driving
inflammation and premature aging. Accumulating data indicate that underlying inflammation strongly contributes
to PWH continuing to develop non-communicable diseases (NCD) despite viral suppression, with studies
showing a 2-fold increased risk of a significant NCD, HIV-associated stroke, compared to people without HIV.
HIV-associated stroke is associated with major mortality, morbidity, and healthcare economic burden. The
current investigators found a stroke prevalence of 6.2% in South African PWH with suppressed viral loads
compared to people without HIV. PWH were almost 10 years younger, had less traditional cardiovascular risk
factors, and were predominantly female, despite being virally suppressed to <200 copies/mL. Additionally, HIV
was found to be the predominant risk factor for young stroke (≤45 years) in a Malawian case-control study of
222 PWH and 503 population controls with acute stroke, with an adjusted odds ratio of 5.57 (2.43-12.8).
However, none of these studies examined imperfect adherence as a risk factor for stroke.
Research on the treatment success of ART focuses primarily on perfect or near-perfect adherence strategies
to suppress HIV viral loads to below clinically-relevant thresholds, currently defined as <200 copies/mL. In clinical
practice, however, adherence to ART is often imperfect, with a cohort study from South Africa and Uganda
showing that despite most participants being classified as virally suppressed, adherence across several
categories of PWH was poor. This was confirmed in a study of 64 virally suppressed participants in whom 47%
had detectable viremia between 0-50 copies/mL despite adherence rates over the preceding two months of 93%
(82%-98%) using unannounced pill counts. Others have shown that lower concentrations of intracellular tenofovir
diphosphate (TFV-DP) on dried blood spots (DBS), an objective drug concentration biomarker indicating
cumulative adherence over the preceding 8 weeks, was associated with a 2-fold higher odds of viremia between
20-200 copies/mL.
Investigating imperfect ART adherence in virally suppressed PWH with stroke offers an opportunity to gain
new insights into a potential modifiable factor to reduce stroke. This exploratory study will obtain important
preliminary data on the association between stroke and ART adherence, as well as the novel approach of testing
candidate proteomic biomarkers for the identification and prediction of stroke in virally suppressed PWH. We will
test the hypothesis that imperfect ART adherence sufficient to suppress HIV viral loads to <200 copies/mL
is insufficient to control viremia below this threshold, and is associated with inflammation leading to stroke.

Public health relevance
PROJECT NARRATIVE The risk for stroke is two-fold higher in people with HIV (PWH) compared to people without HIV, despite antiretroviral therapy (ART) and viral suppression, and without many of the traditional stroke risk factors, suggesting ongoing HIV-associated inflammation as a potential driver of stroke risk. Adherence to ART sufficient to suppress viral loads to below the clinically-relevant threshold of 200 copies/mL may not be adequate to suppress viremia completely, with ongoing HIV-associated inflammation. We will conduct a comparative observational study in virally suppressed PWH presenting with stroke compared to PWH without stroke to obtain preliminary, exploratory data on the association between stroke and imperfect adherence to ART, viremia and the viral reservoir, and exploratory proteomic biomarkers.